Design of a self-tunable mRNA circuit to control cellular protein levels

Project Summary
Imbalances in protein levels disrupt the cellular homeostasis, leading to impaired cell function and
the onset of diseases. Maintaining precise control over protein concentrations in cells, both the
endogenous and therapeutic exogeneous proteins, is critical for therapeutic homeostasis. While
the proteolysis-targeting chimera (PROTAC) technology is a newly emerged approach that
removes disease-associated proteins by leveraging cellular programmed degradation machinery,
the challenge lies in achieving long-term, precise control of the target protein within the
therapeutic concentrations. The proposal aims to address this challenge by developing an mRNA-
based gene circuit capable of sustained, accurate regulation of a target protein in cells. Utilizing
advanced in silico peptide docking and innovative cell-based screening approaches, the circuit is
designed to implement the PROTAC strategy for optimal protein concentration control. This proof-
of-concept study aims to develop a modular, self-tuning mRNA gene circuit adaptable across
diverse biological systems. By integrating experimental validation with a mathematical kinetic
model for regulating target protein concentrations, this approach will facilitate the design of
personalized therapeutic regimens and provide predictive insights into treatment outcomes. Aim
1 of the proposal focuses on the design and validation of one of the two modules that directs
programmable degradation of the mRNAs expressing PROTAC proteins. Aim 2 will combine the
two modules, measure the efficiency of the gene circuit in degrading and maintaining the cellular
level of the target protein, and validate the mathematic kinetic model. The platform developed in
this study holds significant potential for advancing precision medicine in the future.

Public health relevance
Project Narrative The aberrant expression of a protein can lead to disruptions in cellular pathways, impairment of functionality impairment, degeneration, cell death, and ultimately disease manifestation. The proposed research aims to develop a self-tunable genetic circuit platform to regulate the cellular level of a target protein to maintain the normal homeostasis. This innovative synthetic biology strategy holds great promise for advancing precision medicine.